Red Cell Biology

There are three related projects in this program: Project 1: Genome sequencing to identify DBA mutations. Project 2: In vitro culture and epigenetic profiling of DBA patient cells. Project 3: Novel mouse models of red blood cell functions. DBA is an inherited bone marrow failure syndrome in which ribosome defects specifically block erythropoiesis while cells of the other hematopoietic lineages are normal in both number and function. In addition to anemia, DBA shares several clinical features with other bone marrow failure syndromes, e.g. Fanconi anemia and Schwachman Diamond syndrome, including: 1) a high frequency of birth defects, 2) a predisposition to cancer (both solid tumors and AML) and 3) variable penetrance and clinical course, ranging from asymptomatic to severe. DBA is inherited as an autosomal dominant with incomplete penetrance and 60% of DBA mutations arise de novo. Despite the phenotypic variation observed among patients with DBA, only a few confirmed genotype/phenotype correlations have been established. Project 1. Mutations in at least 15 different ribosomal protein (RP) genes have been identified in 65% of DBA patients. These mutations lead to aberrant rRNA processing, impaired production of either the small or large ribosomal subunit and reduced numbers of mature 80S ribosomes. Targeted sequencing of the 80 ribosomal protein genes in >75 DBA patients without a molecular diagnosis failed to identify causative mutations in 35% of DBA patients. Our exome sequencing of 12 DBA patients with no identifiable RP mutations from the resequencing cohort, also did not identify causative mutations in any other genes. Identifying and characterizing the remaining 35% of DBA mutations is the goal of Project 1. We have used whole genome sequencing to screen DBA patients for small deletions in and around ribosomal protein genes. In our first 6 patients we have identified 4 deletions which are too small to be detected by other methods, which we believe cause DBA in these patients. We have validated these as causative mutations and will be submitting the paper shortly. (Vlachos et al, in preparation). Project 2. An unresolved question regarding the pathogenesis of DBA is the precise stage at which erythroid differentiation is blocked. We have shown that the MEP population contains 45% erythroid primed cells34, suggesting that the failure of erythropoiesis in DBA may involve a more primitive Pre-MEP or HSC population. We hypothesize that CD34+ progenitor cells from patients with DBA will be deficient in erythroid primed progenitor cells. We have used single cell RNA profiling to identify the cell populations affected in DBA and found that DBA patients are deficient in the earliest erythroid progenitors, much earlier in hematopoiesis that the current models predict. DBA patients are treated with red cell transfusions, usually followed by a trial of corticosteroid therapy around the age of three years. Durable steroid-induced erythropoiesis is seen in approximately 30-40% of DBA patients. In addition, 15% of DBA patients undergo spontaneous remission and begin relatively normal erythropoiesis for periods of several months to many years. We hypothesize that the variable response to steroid treatment and spontaneous remission is due to changes in the epigenetic profile in DBA progenitor cells. We further hypothesize that the identification fo these regions will identify critical targets for future therapeutic interventions. In the second part of Project 2 we will investigate the epigenetic profile of erythroid cells cultured from DBA patients. We have preliminary data from over 35 patients demonstrating specific and reproducible differences in DNA methylation and chromatin accessibility (ATAC-Seq) that correlate with transfusion dependence, steroid responsiveness and remission. We are recruiting more steroid-responsive DBA patients and DBA patients in remission to identify specific epigenetic changes associated with the restoration of erythropoiesis. Project 3 will investigate two novel hypotheses about erythrocyte production and function and red cell metabolism. Mammalian red cell deformability and metabolism changes between low oxygen (tissues) and high oxygen (lung) environments. In hypoxic conditions red cells show increased deformability, increased ATP release and pentose pathway activity, while in normoxic conditions red cells revert to normal deformability and activate the glycolysis pathway to produce ATP. A candidate for the oxygen sensor is band 3, the protein encoded by the Slc4a1 gene. Band 3 is the most abundant protein in the mammalian erythrocyte membrane and functions as an anion exchange channel. In vitro, the N-terminus of the cytoplasmic domain of band 3 reversibly binds glycolytic enzymes in normoxic conditions and deoxyhemoglobin in hypoxic conditions but the in vivo function of this reversible binding has not been studied. In sickle cell disease (SCD), polymerization of deoxyhemoglobin S is the fundamental lesion underlying the multi-organ damage that characterizes the disease. DeoxyHbS forms long insoluble polymers that distort the red cell into the characteristic sickle shape. A paradox in the study of SCD is that the polymerization of HbS within red blood cells occurs at 10-fold higher concentrations of oxygen than the polymerization of HbS in vitro. We will test the hypothesis that the binding of deoxyhemoglobin to band 3 is the switch controlling the oxygen dependent changes in deformability, glycolysis and HbS polymerization. The red blood cells of an average adult human male store collectively about 2.5 grams of iron, representing about 75 percent of the total body iron. The continuous production of new red blood cells requires iron, some supplied by the diet and the remainder by macrophages which engulf senescent red blood cells and recycle iron to maturing red cells. Iron metabolism models predict that the iron required for heme synthesis (and therefore hemoglobin assembly) is imported into erythroid cells as transferrin and subsequently incorporated into heme by a series of enzymes associated with the mitochondrial membrane. To keep the levels of heme and globin chains balanced (excess heme is toxic), immature red cells express a heme exporter, FlvcR, which is expressed at its highest levels at the CFU-E stage before declining during terminal erythroid maturation (basophilic erythroblast to reticulocyte). However, the translation of globin mRNA peaks during the most terminal stages of erythroid maturation (orthochromatic erythroblast and reticulocyte) between which the nucleus is extruded and most of the heme producing mitochondria degrade. How then do reticulocytes generate enough heme to complete hemoglobin assembly? We have knocked out a novel heme transporter, HRG1 to answer this question and found that HRG1 deficient mice sequester heme in the lysosomes of splenic and bone marrow macrophages. The sequestered heme is in the form of hemozoin a crystalline form of heme that is non-toxic and heretofore only observed in malaria parasites (eLife in press). These data suggest that blocking HRG1 would be a good way to prevent iron overload.